Structural analysis of tetherin-mediated HIV restriction

DESCRIPTION (provided by applicant): Tetherin is a HIV restriction factor that prevents release of enveloped viruses by mechanically linking the virus to the host cell membrane. This requires membrane insertion of tetherin's transmembrane domain and GPI anchor, as well as dimerization of tetherin's cytoplasmic ectodomains. The precise geometric arrangement of tetherin molecules and tetherin domains at sites of HIV-1 restriction are not well understood. Tetherin is recruited to discrete sites on the plasma membrane that correspond to regions of HIV-1 assembly and budding. The goal of this research proposal is to elucidate the three-dimensional (3D) structure of tethered HIV-1 virions and virus like particles (VLPs) and the tetherin microdomain. Specific Aim 1 - characterize the 3D structure of HIV-1 VLPs tethered to the plasma membrane of a mammalian cell by cryo-electron tomography (cryo-ET). Specific Aim 2 - characterize the 3D structure of the tetherin microdomain in HIV-1 permissive cells by correlative light electron microscopy (CLEM).

Public health relevance
PUBLIC HEALTH RELEVANCE: This project addresses several questions of critical importance to the success of viruses that are pathogens of humans and other animals. Tetherin is a HIV restriction factor that prevents release of enveloped viruses by mechanically linking the virus to the host cell membrane. Several fundamental questions regarding tetherin structure and function remain unanswered. The structural studies I have proposed will enable me to determine the native structure of tetherin and its proximity to tethered HIV-1 virions and virus like particles. The second set of studies will provide us with a model system from which to explore viral host-pathogen interactions in human cells unprecedented detail. The knowledge gained in the proposed study may be translated into the development of therapeutics and vaccines to improve public health.